Team-Based Design for Clinical Translation

PROJECT SUMMARY
The overall objective of this proposal is to infuse clinical inspired design throughout a biomedical engineering
curriculum. We propose to develop a summer clinical immersion program based on the value of multi-
disciplinary input and interactive student mentoring in problem finding. Deliverables from the summer
experience will impact courses throughout the curriculum by providing open-ended, problem-based case
studies that will engage aspects of design thinking and application of specific course material. The summer
experience will also seed projects for a senior design course, focused on the creation of medical device
prototypes and skills development that emphasize multidisciplinary communication. To promote co-learning
and the further integration of design across the curriculum, senior student teams will apply their learning to lead
workshop activities in other classes. This will serve to connect different level thinkers and experiences across
student cohorts. The proposed project has strong enthusiasm and commitment from established partnerships
between biomedical engineering faculty, clinicians in the College of Medicine, clinicians in the College of
Veterinary Medicine, industry leaders, and administration. Our goal is to emphasize translational opportunities
throughout the maturation of novice problem solvers to open-ended decision makers. Specifically, the new
summer clinical immersion experience will bi-directionally integrate the value of design thinking across the
department through the completion of the following inter-related aims:
Aim 1: To develop and implement a summer clinical immersion program with multi-disciplinary input and
enhanced student interaction.
Aim 2: To seed fundamental biomedical engineering courses across the curriculum with clinically inspired
design problems.
Aim 3: To facilitate bidirectional co-learning to enhance the senior design and entire biomedical engineering
curriculum.
Biomedical engineering at UF is primed to make the proposed jump in design education based on over 40
established relationships with clinicians, the existing engagement of 13 industry partners, and a developing
curriculum that makes design integration possible. The proposed course and programmatic innovations will
provide a curriculum model that can be disseminated to other departments with the overall goal of enhancing
biomedical engineering design education to ensure students self-identity as clinical translators.

Public health relevance
NARRATIVE Empowering biomedical engineers to be open-ended problem solvers will impact technology advancement in healthcare. However, the necessary skill development and exposure to clinical problems is often not consistent enough in undergraduate curriculums. The overall objective of this proposal is to develop a summer clinical immersion experience that will spark bi-directional integration of design thinking across a biomedical engineering curriculum.